Cellular and molecular mechanisms that modulate synaptic function and plasticity

A gap in knowledge remains regarding how specific molecular changes that alter synaptic physiology actuate
particular behavioral preferences and memories in living animals. Knowledge on how the cell biology of
synapses is altered in the actuation of memories is of critical importance in our aspiration to understand how
the building blocks of the nervous system come together to produce its functional output, behaviors. The
overall objective of this proposal is to determine how C. elegans synapses between the thermosensory neuron
AFD and its only postsynaptic partner (AIY) are modified by experiences to express a learned temperature
preference. Our central hypothesis is that temperature preference memory is actuated in AFD through
presynaptic plasticity, which is in turn regulated through Protein Kinase C epsilon/eta (nPKCε)-dependent
mechanisms. Our hypothesis is based on our preliminary studies and published findings that indicate that
altering nPKCε activity in a single neuron (AFD) is sufficient to change the temperature preference of the
organism regardless of previous experience. We found that nPKCε localizes near presynaptic sites and alters
transmission of AFD sensory information to its postsynaptic partner (AIY). The rationale of the proposed aims
is that we can use the compact neural circuitry of C. elegans to dissect how conserved molecules, like nPKCε,
regulate presynaptic plasticity to modulate experience-dependent adaptive behaviors. We propose to use
genetic, cell biological, pharmacological, behavioral and calcium imaging approaches to achieve our three
specific aims: (1) Identify the role of nPKCε in modulating the AFD:AIY chemical synapse; (2) Identify the
molecular mechanisms that regulate nPKCε activation; and (3) Identify the presynaptic plasticity mechanism
regulated by nPKCε. Upon successful completion of the proposed aims we expect the contribution to be a
detailed molecular and cell biological understanding of how the temperature preference memory is actuated in
vivo through the regulation of presynaptic plasticity mediated by the conserved nPKCε pathways. The technical
and conceptual innovations in this proposal open up new horizons by providing access to the hubs of memory
actuation in living animals and with cell biological resolution. We anticipate, because of the molecular
conservation of the examined pathways, that advancements in our understanding based on these innovations
will result in transposable lessons of broad biological significance.

Public health relevance
The proposed research is relevant to public health because it will result in a deeper understanding of the molecular mechanisms underlying synaptic plasticity in the neural circuits of living organisms. Synaptic plasticity influences the functional output of the nervous system, behaviors. The genes that support synaptic plasticity have been implicated in disorders ranging from intellectual disability to epilepsy. Because these molecular mechanisms are conserved throughout evolution, the findings emerging from the completion of the proposed work will result in broad conceptual insights that will inform our understanding of how these processes could go awry in disease.